Linking systemic and local signaling for proportional growth

Proportional growth ensures overall size is coordinated with organ and limb size to generate the correct animal
body form. In all animals, body size is determined by a plastic response to environmental factors such as
nutrition. The TOR pathway senses amino acids and, together with the insulin pathway and hormones, regulates
growth to produce an overall size best suited for the conditions, such as a small organism if food is limiting. Local
growth of organs and limbs is more autonomous and robust so that the final structure is correctly patterned while
scaled for overall body size. For example, fly wings of different sizes have the same stereotypical pattern of
veins, intervein regions, and sense organs needed to produce a functional wing. The long-term goal of this
project is to understand how systemic signaling and local growth are coordinated in the gene regulatory network
(GRN) for Drosophila wing development. The goal for this proposal is to investigate the first circuit in the GRN
when it is hypothesized that a systemic signal activates local growth pathways to induce the first cell divisions in
the nascent wing disc. The fly wing is a flagship model for analyzing signaling and appendage growth and
patterning; however, there is a gap in knowledge about the earliest stage of wing disc development. This stage
is poorly understood because the tiny disc is comprised of only approximately 30 cells. Expertise in handling the
small samples, exemplified in preliminary data, show size is not a barrier to gaining mechanistic insights into the
nature of the systemic signal and determining which local growth pathways are sensitive to it. In Aim 1,
experiments will test the hypothesis that insulin signaling is the systemic input that stimulates wing cell growth
and activates a morphogenetic pathway(s) to initiate the cell cycle. Genetic manipulation, antibody staining, and
imaging will be used to determine if modulation of insulin signaling regulates cell cycle dynamics in the wing disc.
In Aim 2, the target pathway(s) of the systemic signal will be identified. The pathways under investigation are the
major growth and morphogenetic pathways; Dpp, Wingless, Egfr, Hedgehog, and Notch, which are required for
correct patterning and growth of the wing disc. Pathway markers and targets will be used to monitor activity in
starved and fed larvae. Pathways that are sensitive to nutrition for activation are candidates for response to the
systemic signal. The role of these pathways in cell cycle initiation will be determined by using genetics to activate
or repress a given pathway followed by assaying the cell cycle. Preliminary data show that Egfr activity is
sensitive to nutrition and required for cell cycle progression. The results strongly support feasibility of the
approach but leave open the question of how direct the link is between the Egfr pathway and the systemic signal.
In the last part of Aim 2, the interrelationships of the morphogenetic pathway to each other and to the systemic
signal will be analyzed. As well as being a fundamental question in development, proportional growth also has
health and wellness implications. Altered body forms can lead to stigmatization, influence susceptibility to
disease, and in the case of limb abnormalities, occur in 1/1900 births.

Public health relevance
NARRATIVE This project will analyze how parts of the body (limbs and organs) grow in concert with overall body size, using the model Drosophila system, which leads the field in discovering growth mechanisms shared with other animals, including humans. In the long term, this knowledge will help in understanding human conditions that alter body proportions or cause birth defects that reduce limbs.